Next Generation Training in HIV Research: Immunity in the First 1000 days in mother-infant dyads (TIGRIS)

Project Summary
We propose an innovative and unique HIV training program: NexT generation traininG in
HIV Research: Immunity in the First 1000 days in mother-infant dyadS” (TIGRIS). The program will leverage
existing NIH funding to investigate specific hypotheses related to how HIV infection in the pregnant woman leads
to adverse birth outcomes and ensuing pediatric immune dysfunction through rigorous clinical and basic science
laboratory training. TIGRIS is a multidisciplinary, international and intercontinental African HIV training program.
The program will be implemented at Stellenbosch University (SU) in South Africa along with the Mayo Clinic,
Rochester, USA. Mentorship will be provided by our extensive international Faculty in the US (Morehouse
School of Medicine, Stanford University, Duke University, Weill Cornell Medical College, University of
Cincinnati – Cincinnati Children’s Hospital Medical Center, Seattle Children’s Research Institute and
Harvard University), Canada (University of Toronto) and in the UK (Universities of Cambridge and Surrey)
to provide laboratory training for existing registered MMed, PhD and Post-Doctoral Fellows through short- and
medium-term laboratory training in South Africa and in LMICs in west, east and southern Africa. This training will
strengthen laboratory investigations and generate novel data by having access to state-of-the-art technologies
and data analysis. By so doing, the over-arching aim of TIGRIS will be to strengthen HIV research by studying
reproductive and neonatal immunology in Africa and specifically around mother-infant dyads during maternal
HIV infection. TIGRIS has three specific aims: 1) Create and implement a short- and medium-term laboratory
training program in reproductive immunology in the context of maternal HIV infection in pregnancy; 2) To
launch and sustain a two-semester structured didactic post-graduate course in reproductive and neonatal
Immunology that will supplement and enrich existing training for Clinician Scientists, graduate students working
towards PhD degrees, and Post-doctoral Fellows; 3) To create bilateral engagement between Stellenbosch
University and the Mayo Clinic with Benin, Kenya, Malawi and Uganda. We have successfully used a D71
planning grant to establish the Reproductive Immunology Research Consortium in Africa and to hold stakeholder
meetings that has shaped this D43 application. We will continue to leverage existing funded projects to
implement training in reproductive and neonatal immunology research, to enhance immunology knowledge
capacity and use our extensive expertise of training in Africa for grant writing sessions that will equip young
clinical and PhD-based researchers in the field of HIV research to be emerging global leaders.

Public health relevance
Project Narrative This D43 is a multidisciplinary, international, and inter-African continental HIV research training program: NexT generation traininG in HIV Research: Immunity in the First 1000 days in mother-infant dyadS” (TIGRIS). We will institute a laboratory-based training program to investigate how HIV infection in the pregnant woman leads to adverse birth outcomes and neonatal immune dysfunction and complement this with didactic two- semester course in HIV and reproductive immunology that will enhance HIV scientific capacity in Africa.